Investigation of the effect of lens refractive index on the measurement of axial length of the human eye for accommodation and cataract surgery

SUMMARY/ABSTRACT
Measurements of the axial length (AL) of the eye have wide applications in eye research and the clinical
practices of optometry and ophthalmology. The accuracy of AL measurements directly affects research studies
results and the quality of vision-related clinical treatments. Current methods to measure AL make assumptions
of the refractive index of the crystalline lens (NLens) that may induce significant measurement errors. It is
therefore highly important to measure the NLens of individual eyes. Measurement of the NLens of the human eye
in vivo has for long been a challenge, and as of today there are no practical methods to measure the NLens.
One of the PIs (Dr. He) has recently developed a method to measure the NLens in vivo using a ray-traceable
Scheimpflug imaging (RTSI) system combined with an anterior segment OCT. Another PI (Dr. Wang) has
used a whole-eye OCT (WE-OCT) to measure AL before. The primary goal of the proposed project is to
combine the RTSI with a whole-eye OCT (WE-OCT) to simultaneously measure the NLens and AL in human
eyes in vivo. With this novel, non-contact system, the measured NLens will be used to derive accurate AL
measurements for individual eyes. The system will be used to measure the change in the NLens and AL for a
group of young adults during accommodation. The results of this study may provide highly significant insights
in the possible role of accommodation in myopia development, as well as a method that can be used in clinic
when measuring AL for myopia control purposes. This novel system will also be used to measure the NLens and
AL for a group of patients with cataracts, both pre- and post-operatively. The results of this second study may
be used to analyze the impact of measurement error of the AL due to using an average NLens on the visual
quality of these patients after IOL implantation. Successful completion of the studies proposed here will allow
us to: (1) better understand the mechanism underlying myopia development, (2) obtain more accurate
measurements of AL during clinical care of patients with myopia, and (3) understand the impact of NLens
measurement on AL measurement prior to cataract surgery. The proposed technique is highly impactful and
will pose a substantial breakthrough in the methodology for accurately measuring AL of the human eye in
research and clinical practice.

Public health relevance
PROJECT NARRATIVE Measurement of the axial length (AL) of the eye has wide applications in eye research and clinical practice; however, it relies on an estimate of the refractive index of the lens (NLens), which has never been accurately measured for individual eyes in vivo. The primary goal of this proposed project is to combine a ray-traceable Scheimpflug imaging system (RTSI), developed recently by the contact PI, Dr. He, with a whole-eye OCT (WE- OCT) to measure the (NLens) and axial length (AL) simultaneously for human eyes in vivo. This system will be used to derive accurate AL measurements for a group of young adults and cataract patients and will present a substantial breakthrough in the methodology for accurately measuring the AL of the eye.